Advanced molecular engineering approach for understanding extracellular vesicle in vivo trafficking mechanism

ABSTRACT
Deciphering extracellular vesicles (EVs) mediated cell-to-cell communications at the molecular precision has
been a grand challenge. Mechanistic understanding from current laboratory investigation presents a substantial
knowledge gap from clinical translation. Different cell sources derived EVs carry completely different surface
receptors and regulatory molecular components. Heterogeneous populations of EVs confound the investigation
of key drivers in cellular regulation, for poorly understanding mechanisms on either crossing biological barrier or
extracellular matrix accumulation. To date, the molecular mechanisms on tissue targeting specificity are lacking,
and the therapeutic potential of different subpopulations of EVs is unknown yet. The proposed research tackles
those key challenging questions by introducing a series of advanced molecular engineering approaches for
precisely predicting, defining, and in vivo testing EV surface receptor and antigenic presentation. Specifically,
project #1 will develop CRISPR imaging technology for understanding molecular mechanism on EV tissue
penetration and accumulation. Project #2 will develop artificial intelligent direct-flow generative adversarial model
(ExoGAN) enabled construction of specific targeting EVs. Project #3 will develop microfluidic single cell single
vesicle transwell system for deciphering effective MHC presenting modulators engaged in EV mediated
immunity. This proposal will build a foundation to facilitate mechanistic -driven tissue targeting for advancing
precision drug delivery and open broad applications to precision drug delivery.

Public health relevance
PROJECT NARRATIVE The extracellular vesicle (EVs) in vivo trafficking mechanism has not been well understood, especially for crossing blood-brain barrier and specific tissue trafficking. The proposed projects will set technology and knowledge foundation to facilitate mechanistic -driven tissue targeting utilizing EV route, and open broad applications to advance gene therapy and immunotherapy.